HMG-1 IN POST-OPERATIVE AND TRAUMATIC SEPSIS

Mortality following surgery is caused primarily by complications of infection, but limited understanding of pathogenesis has hampered the development of new therapeutics. Endotoxin produced by all Gram- negative bacteria is lethal to mammals because it stimulates macrophages to release TNF and other potentially lethal factors. Maximal TNF levels are achieved within two hours after dosing with endotoxin; this timing is critical because even minimal delays in administering treatment against early mediators renders them ineffective. Paradoxically, endotoxin- poisoned animals succumb at latencies up to five days after the onset of endotoxemia, long after serum levels of the early cytokines TNF and IL-1 return to basal levels. Dr. Tracey and his colleagues recently identified a previously unrecognized "late" mediator of endotoxin lethality, a ubiquitous protein known as "high mobility group-1" (HMG-1) (Science, 1999, 285: 248-251). Endotoxin stimulates LPS-sensitive macrophages to release HMG-1; LPS-resistant macrophages from C3H/HeJ mice fail to release HMG-1. Serum HMG-1 levels are significantly increased from 16 to 32 hours after endotoxemia in mice. In serum from patients with surgical sepsis, high HMG-1 levels were associated with lethal outcome. Administration of rHMG-1 to mice is lethal, and delayed administration of anti-HMG-1 antibodies significantly protects against lethal endotoxemia, even when antibody administration is delayed until after peak TNF release. To date however, the effects of anti-HMG-1 or HMG- 1 itself in a clinically relevant animal model of trauma, injury, or hemorrhagic shock are unknown. Trauma and shock are known to induce a state of altered cytokine responsiveness in which macrophage activation states are deranged. It is theoretically possible that anti-HMG- 1 antibodies used in this setting would not improve survival; they may actually be deleterious. The objective of the studies outlined in this proposal is to determine whether HMG-1 mediates beneficial or injurious responses in the altered cytokine milieu of posttraumatic sepsis. The experiments proposed in the Specific Aims will define the effects of HMG-1 and antiHMG-1 antibodies in a clinically relevant model of sepsis in animals subjected to surgery and hemorrhagic shock. Studies of the binding and uptake of HMG-1 in human and murine monocytes, and the stimulation of cytokine release by HMG-1 itself, will yield important new information concerning the endogenous mechanisms underlying the systemic response to shock and sepsis.